Peptide-Mediated Enhancement of Akt During Resuscitation and Reperfusion

PROJECT SUMMARY/ABSTRACT
Out-of-hospital cardiac arrest is a significant public health burden, affecting over 350,000 people annually in the
United States. Survival remains less than 12% and long-term neurological deficit is common in survivors.
Currently no drugs exist to reverse myocardial stunning or improve long-term survival with good neurological
outcome, which highlights an urgent and unmet need in resuscitation. Pharmacological stimulation of cardiac
glucose oxidation represents a potential key strategy for enhancing recovery and reversing a pathological
increase in fatty acid oxidation which occurs after ischemia, although agents such as dichloroacetate are limited
by toxicity. A novel cell-penetrating peptide, TAT-PHLPP9c, was developed which rapidly gains access to tissues
and selectively inhibits PHLPP1, thereby enhancing activation of Akt. In a mouse model of cardiac arrest,
intravenous administration of TAT-PHLPP9c during CPR improves recovery of cerebral blood flow and enhances
activation of both Akt and pyruvate dehydrogenase in the heart and brain. In swine, administration of TAT-
PHLPP9c during mechanical CPR significantly improves 24-hour survival. Agents such as TAT-PHLPP9c that
quickly gain access to tissues to improve survival would represent a significant advancement in resuscitation.
Targeting metabolic dysfunction with TAT-PHLPP9c may decrease the circuit flow rate needed for successful
eCPR, which will allow for narrow cannulas to be used and may lead to wider availability of eCPR. Using high
resolution magnetic resonance methods, this project will investigate the mechanisms underlying TAT-PHLPP9c
cardioprotection and neuroprotection. The following hypotheses will be tested: 1) TAT-PHLPP9c directly targets
the heart and enhances functional recovery from ischemia; 2) TAT-PHLPP9c decreases fatty acid oxidation in
the post-ischemic heart; 3) TAT-PHLPP9c treatment during low flow eCPR improves cardiac arrest survival,
neurological recovery, cerebral blood flow, and cerebral metabolism; 4) TAT-PHLPP9c reduces the circuit flow
rate required for successful eCPR; and 5) TAT-PHLPP9c-mediated Akt activation in peripheral blood leukocytes
reflects Akt activation in tissues from vital organs. These hypotheses will be tested using a Langendorff model
of rat heart ischemia/reperfusion injury, a swine model of eCPR, and a mouse model of cardiac arrest. It is our
ultimate goal to translate these findings to emergency resuscitative care in order to save lives and minimize long-
term neurological disability after cardiac arrest. A comprehensive training plan will develop the principal
investigator’s skills as a physician-scientist under the guidance of the sponsor (Terry L. Vanden Hoek, MD,
University of Illinois at Chicago) and co-sponsor (Henry R. Halperin, MD, MA, Johns Hopkins University).

Public health relevance
PROJECT NARRATIVE Cardiac arrest survival remains unacceptably poor and currently no drugs exist that improve long-term survival with favorable neurological outcome. Agents such as TAT-PHLPP9c that target metabolic dysfunction may significantly improve outcomes and decrease the circuit flow rate required for successful extracorporeal cardiopulmonary resuscitation (eCPR), thereby broadening the availability of eCPR to wider populations including underserved areas. The main objective of this project is to evaluate the protective mechanism of TAT- PHLPP9c and its ability to improve the efficiency of eCPR.